Deciphering the mechanism of action of carnitine, a novel treatment for chronic Chagas disease

Project summary/abstract
Chagas disease is a leading but poorly-understood infectious cause of heart failure, resulting from infection
with Trypanosoma cruzi parasites. T. cruzi has a worldwide prevalence of 7 million, with over 300,000 infected
individuals in the United States. Chagas disease causes a significant burden on health care and the economy
of over $7 billion annually in total costs. No vaccines are available, and current treatment options are limited by
significant adverse effects, long treatment duration, and poor efficacy in late-stage disease. New treatment
options for Chagas disease have therefore been identified as a research priority by the World Health
Organization, the World Heart Federation, and the Inter-American Society of Cardiology. Our work has
identified L-carnitine as a novel treatment regimen for acute and chronic T. cruzi infection, able to improve
readouts of cardiac damage and disease severity, and with a good safety profile alone and in combination with
the antiparasitic standard-of-care benznidazole. L-carnitine has high potential for clinical translatability, being
affordable, readily available, and already FDA-approved to treat inborn metabolic disorders. However, the
mechanism of action of L-carnitine in chronic T. cruzi infection is currently unknown. The overall objective of
this proposal is to elucidate this mechanism of action, enabling in the long-term continued development of L-
carnitine into clinical implementation, and the identification of new alternative treatment regimens for Chagas
disease. L-carnitine differs from classic antiparasitic agents in that it improves T. cruzi infection outcomes
without reducing parasite load. Thus, results will also expand our understanding of Chagas disease
pathogenesis. The central hypothesis of this proposal is that L-carnitine’s mechanism of action is mediated by
lessening cardiac fatty acid oxidation, increasing cardiac glucose metabolism, and lowering infection-induced
cardiac contractile impairment. This central hypothesis will be tested in experimental models of chronic T. cruzi
infection, using three complementary yet independent aims. We will combine metabolomic and
pharmacological analyses of the impact of L-carnitine on fatty acid oxidation (aim 1) and on glucose oxidation
(aim 2) with echocardiographic analyses of the impact of L-carnitine treatment on cardiac contractility (aim 3).
The proposed research is innovative because it centers around a new candidate treatment regimen for Chagas
disease with novel mechanism of action, and it will lead to the identification of additional avenues for Chagas
disease treatment. The proposed research is significant because it will lead to a rigorous understanding of L-
carnitine’s mechanism of action, facilitating its progression to the clinic, and will identify novel candidates for
further Chagas disease drug development. Overall, this work will provide valuable new translational
avenues for Chagas disease treatment, as well as significant fundamental insight into cardiac Chagas
disease pathogenesis.

Public health relevance
Project narrative Chagas disease, caused by Trypanosoma cruzi parasites, is an important cause of heart failure with no effective treatment in late-stage disease. This project will build on our findings that L-carnitine treatment improves chronic Trypanosoma cruzi infection severity, to determine the mechanism of action of L-carnitine in chronic Chagas disease treatment. This project is relevant to the NIH’s mission because results will guide L- carnitine pre-clinical and clinical development, identify new avenues for Chagas disease patient treatment, and expand our understanding of Chagas disease pathogenesis.